Targeting neuronal transport to ameliorate vincristine neurotoxicity

Abstract
Microtubule-binding chemotherapeutics such as vincristine are among the most widely used anticancer agents
in oncology for the treatment of multiple solid tumors and leukemias in children and adults. The clinical use of
vincristine is associated with a debilitating, dose-limiting peripheral neurotoxicity for which no effective
preventative treatments are presently available. In addition, the mechanism by which vincristine accumulates
into dorsal root ganglion (DRG) neurons remains unclear to this day. Using a transporter screen of xenobiotic
uptake carriers in heterologous overexpressed models, we recently found that the organic anion transporting
polypeptide OATP1B3 (in mice, OATP1B2; collective referred to as OATP1B2/3) is an efficient transporter of
vincristine that is expressed in human and mouse DRG neurons. Functional validation studies in OATP1B2-
deficient mice and secondary screens confirmed that vincristine is transported into DRG neurons by OATP1B2.
Furthermore, deficiency of OATP1B2 protected mice from vincristine-related changes in various hallmarks of
peripheral neurotoxicity without altering the plasma levels of vincristine. To provide proof-of-principle and
demonstrate translational relevance of this transport mechanism, we found that several known
pharmacological inhibitors of OATP1B, including rifampin and the tyrosine kinase inhibitor, nilotinib, can
preserve DRG neuronal function following treatment with vincristine without affecting its plasma levels or its
cytotoxic potential against multiple acute leukemia cell lines. Finally, we identified α-tocopherol (vintamin E) as
a previously unrecognized biomarker of neuronal OATP1B2/3 function that can be measured in the systemic
circulation, and we validated the translational utility of this biomarker in a mouse model receiving treatment
with OATP1B inhibitors. Based on these preliminary findings, we now outline three sets of related studies that
will further test and refine the validity of our central hypothesis that targeted modulation of OATP1B2/3 function
with optimized doses and schedules of novel OATP1B2/3 inhibitors can specifically affect accumulation of
vincristine in DRG neurons and affect downstream toxic events without negatively influencing its plasma
pharmacokinetic profile or anti-leukemic properties: (i) mechanistic characterization of nilotinib as the proof-of -
principle OATP1B inhibitor, and identification and validation of additional modulators derived from a library
screen that includes FDA-approved agents; (ii) biomarker-driven optimization using α-tocopherol as a
companion diagnostic to guide dose selection of OATP1B modulators for in vivo testing; and (iii) safety and
efficacy analyses of optimized combinatorial regimens of OATP1B inhibitors with vincristine, including
simultaneous assessment of neuroprotection and anti-leukemic properties in established experimental models
of acute leukemia. It is expected that these collective studies will not only shed light on the etiology of
vincristine-induced peripheral neurotoxicity, but will be of translational relevance and provide a rationale for the
future implementation of novel targeted intervention strategies to prevent this debilitating side effect.

Public health relevance
Project Narrative The microtubule-binding agent vincristine is among the most effective and widely prescribed anticancer agents, but its clinical use is associated with dose-limiting damage to peripheral neurons (neurotoxicity). Using unique genetic mouse models, we found that acute and chronic forms of neurotoxicity caused by vincristine are dependent on an uptake process in neurons that is mediated by the transporter OATP1B2 (in humans, OATP1B3). The proposed studies are a logical continuation of our mechanistic studies, and will directly test the hypothesis that targeted interference of OATP1B2 and OATP1B3 with pharmacological inhibitors can mitigate the incidence and severity of this debilitating side effect without affecting the agent’s anticancer properties.